EGFR ANTIBODY 225 IN METASTATIC RENAL CELL CARCINOMA

The purpose of this study is to determine whether the time to progression in patients with metastatic renal cell carcinoma is doubled from 4 months (historical control data) to 8 months following the initiation of treatment with C225 when administered by weekly intravenous infusions at a loading dose of 400 mg/m2 followed by maintenance doses of 250 mg/m2. This is a multicenter, open label, non-randomized Phase II study with a single dose level. Patients will receive a "test dose" prior to the initial loading dose only. The patient will receive a 10 mL (20 mg) infusion over 10 minutes and will be observed for a period fo 30 minutes post administration for signs of anaphylaxis. Patients may receive the remainder of their infusion following completion of the observation period. All patients will receive C225 at a loading dose of 400 mg/m2 followed by maintenance doses of 250 mg/m2 IV weekly for seven weeks. In the absence of progressive disease or intolerable toxicity, patients may continue to receive further courses of weekly treatment with C225 for a maximum treatment course of 6 months (i.e., 3 courses). Subsequent courses of therapy will be administered at the maintenance dose level of 250 mg/m2 for 8 weekly doses. Folowing the initial 6 months of treatment, patients who have not progressed may continue to receive treatment for an additional 6 months.